Chronic Health Conditions in Survivors of Down Syndrome-Associated Leukemia

SUMMARY
Down syndrome (DS) is a genetic disorder characterized by a constitutional trisomy of chromosome 21,
neurocognitive delay, phenotypic features, co-occurring structural birth defects, and an increased risk for
chronic health conditions (CHC) such as thyroid disease, osteopenia, seizure disorder, and visual/hearing
problems. Children with DS have a 10-20 fold excess risk for acute leukemia (AL) compared with the general
population, and are also at significantly greater risk for acute therapy-related toxicities. However, few studies
have reported late effects of cancer therapy in survivors of DS-AL, and none have investigated whether these
CHC differ from those experienced by children with DS and no history of cancer. Therefore, although a higher
than expected incidence of late effects is reported in DS-AL survivors, the prevalence and severity of these
CHC relative to the CHC associated with DS is unknown. Further, AL treatment confers well-described risks for
deficits in attention, processing speed, and executive function, but only one small case series has investigated
neuro-psychological (NP) outcomes in DS-AL survivors. Due to a systematic exclusion from research based on
their differing baseline health status, DS-AL survivors are an at-risk population that is largely unstudied.
To address this critical knowledge gap, we will characterize late effects experienced by DS-AL childhood
cancer survivors by determining the prevalence and severity of CHC and clinical and NP outcomes in DS-AL
survivors. Recruiting from DS participants in Children’s Oncology Group studies and registries, our methods
include both medical record data abstraction and prospective in-person and survey-based assessments. Aim 1
will establish an annotated and comprehensively-characterized, contemporary cohort of DS-AL survivors. Aim
2 will leverage access to a well-established cohort of DS persons without cancer history to compare CHC and
NP outcomes with those observed in DS-AL survivors. Aim 3 will identify clinical, genetic, and biological risk
determinants of late effects in DS-AL survivors. Based on our strong preliminary data, we hypothesize that the
prevalence and severity of specific CHC and adverse clinical and NP outcomes will exceed those observed in
non-DS AL and in matched DS controls without cancer history. Further, we expect that DS ALL susceptibility
loci will extend to association with risk for CHC, and correspond with incidence of co-occurring birth defects.
Last, we anticipate that shorter telomere length is associated with adverse NP outcomes. Our multi-disciplinary
team has a strong history of collaboration and expertise in leukemia and cancer survivorship (Gramatges), DS-
AL (Rabin), epidemiology of cancer and birth defects (Lupo), DS-associated CHC (Rosser), NP outcomes in
DS survivors (Jacola), and CHC in survivors of childhood cancer (Chow).
With the support of the Children’s Oncology Group, this multi-site, national study will characterize cancer
treatment outcomes in DS-AL survivors. We anticipate our results will improve survivorship care by informing
clinical practice guidelines for DS-AL survivors, mitigating outcome disparities in this vulnerable population.

Public health relevance
PROJECT NARRATIVE Children with Down syndrome are at increased risk for acute leukemia treatment-related toxicities, but few studies have investigated survivorship outcomes in this subgroup. The proposed work will compare chronic health conditions, neuropsychological outcomes, and quality of life in Down syndrome survivors of acute leukemia to age and sex-matched children with Down syndrome and no history of cancer. Our objective is to comprehensively characterize outcomes in survivors of Down syndrome-associated acute leukemia and identify related risk factors, in order to inform clinical practice guidelines for survivorship care of this understudied and vulnerable population.